Methods in Longitudinal Dementia (MELODEM) Initiative

PROJECT ABSTRACT
The search for effective strategies to prevent or treat Alzheimer's Disease and Alzheimer's Disease Related
Dementias (AD/ADRD) is a global public health priority. This search has been exceptionally difficult, reflecting
the complex, multi-factorial processes culminating in AD/ADRD, diagnostic ambiguity, and the intrinsic
challenges of research on diseases of the brain. Methods in Longitudinal Research on Dementia (MELODEM)
is an international initiative to strengthen, harmonize, and promulgate analytic and design approaches for
AD/ADRD research. Launched in 2012, MELODEM convenes an international interdisciplinary group of
researchers (e.g., epidemiologists, neuropsychologists, neurologists, biostatisticians), across career stages, to
identify and address common methodologic challenges in quantitative research on AD/ADRD. These
methodologic challenges—such as selection/attrition, reverse causation, and measurement of cognition and
dementia—have the potential to bias estimates of the extent to which risk factors protect against AD/ADRD or
slow the progression of AD/ADRD. Some biases can be so extreme as to reverse the direction of estimated
effects (e.g., protective instead of harmful). For the past decade—the past 4 with support from an R13 award
from NIA—MELODEM has convened an annual in-person meeting of 30-40 researchers and twice-monthly
web-based meetings on methodologically themed topics. The proposed continuation of our R13 grant will
support annual in-person MELODEM meetings to foster development and dissemination of valid and rigorous
analytical approaches for quantitative research on the prevention and treatment of ADRD, with the goals of (a)
developing new methods when needed, (b) reaching consensus on “best practices” for analytic methods, and
(c) providing a platform to share and teach methods to early-career and established researchers. To continue
working towards rigorous analytical approaches and “best practices,” the MELODEM annual progress meeting
will include both “Data Workshops” and “Discussion Sessions” on topics relevant to current methodological
challenges in AD/ADRD research. The grant will also provide travel support for US researchers to participate in
the annual meeting and ancillary activities. Finally, to sustain the collaborations and ideas discussed during the
meeting, the grant will support post-meeting activities culminating in published reports from the collaborative
research stemming from the conference and connections with a broader group of researchers not able to
attend the meetings in person. These activities include web-based conference calls and small working group
meetings. Support for the proposed MELODEM meetings will strengthen quantitative research methods related
to AD/ADRD, foster a collaborative, interdisciplinary community addressing the most important technical
challenges, and promote rapid adoption of best practices for solving shared technical challenges in research
on prevention and treatment of AD/ADRD.

Public health relevance
PROJECT NARRATIVE This search for strategies to prevent Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD) has been exceptionally difficult, reflecting the challenges of research on diseases of the aging brain. Methods in Longitudinal Dementia Research (MELODEM) is an international initiative that provides a forum for identifying and sharing effective methods to handle these challenges in quantitative research in humans. MELODEM enlists researchers from a variety of disciplines to develop research methods to address these challenges; fosters interdisciplinary conversations and collaborations to understand which methods are most applicable; and accelerates the exchange of new methods between researchers.